Ultrasound-assisted extracellular vesicle engineering and induced release: EVEiR

PROJECT SUMMARY
While nanoparticle-based platforms have become a leading drug delivery platform for treating
various diseases, several challenges remain in current nanomedicine, including toxicity, inefficient
endothelial barrier crossing, rapid elimination, and nonspecific accumulation in the body. Extra-
cellular vesicles (EVs) provide a natural delivery system that can transfer various cellular cargo
to adjacent and distant cells. EVs offer unique advantages for engineering while possessing in-
herent immune evasion capability and tissue penetrating characteristics. However, inefficient
therapeutic cargo packaging and insufficient EV production from cells limit the current EV-based
drug delivery approach.
Chronic inflammatory disease (CID) imposes health and economic burdens on communi-
ties worldwide. Current therapy of CID is neither sufficient nor disease-modifying. Our ultimate
goal is to develop a safe and effective EV-based therapy for CID patients. The overall objectives
in this application are to (i) develop an ultrasound (US)-based platform termed EVEiR (Extracel-
lular Vesicle Engineering and induced Release) for delivering anti-inflammatory cytokine IL10,
and (ii) determine their therapeutic efficacy using an in vitro intestinal model. The central hypoth-
esis is that externally applied mechanical cues using US stimulation and the mechanical proper-
ties of the cell microenvironment may increase the production and function of engineered EVs
(eEVs) derived from mesenchymal stem cells (MSCs) in 3D cultures. We will test the central
hypothesis by pursuing two Specific Aims: 1) Develop US-assisted EVEiR for efficient production
of anti-inflammatory IL10-carrying eEVs (IL10+ eEVs); and 2) Demonstrate the feasibility of IL10+
eEVs derived from MSCs in 3D cultures for targeted delivery of therapeutics. Aim 1 will determine
the efficiency of IL10+ eEV production using the novel US-based techniques. Aim 2 will charac-
terize the properties of IL10+ eEVs and their anti-inflammatory effect using an in vitro intestinal
model. The innovation of this proposal is to utilize the synergy with the impact of non-viral intra-
cellular IL10 packaging in EVs, the unique concept of pulsed US stimulation of MSCs in 3D hy-
drogel constructs for efficient eEV production. In addition, an in vitro intestinal model allows for
efficient characterization of anti-inflammatory IL10+ eEVs in a physiologically relevant environ-
ment. The proposed research is significant because the successful completion of this project will
develop a rapid, cost-effective, and scalable platform to generate MSC-derived therapeutic EVs
for treating CID and facilitate the translation of MSC-derived EVs to the clinic.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it focuses on developing a novel approach to producing therapeutic extracellular vesicles (EVs) for treating chronic inflammatory diseases. Once such strategies have been developed, there is the potential for a significant ad- vance in the successful translation of EV-based therapy to the clinic. The goal of our Trailblazer project is relevant to the part of the NIH's mission that pertains to reducing illness and disability.